The mitochondrial genome in lung disease: a signaling hub linking the persistence and severity of inflammation to recovery

PROJECT SUMMARY/ABSTRACT
The contribution of oxidative mitochondrial (mt) damage to inflammatory lung diseases is undisputed, but
mechanisms underlying this association remain to be elucidated. Emerging evidence, however, points to the
mitochondrial (mt) genome as a signaling hub integrating the initiation and resolution inflammatory responses.
For example, one of the earliest events is reactive oxygen species (ROS) stress-induced oxidative mtDNA
damage. Oxidized fragments of the mitochondrial genome (ox-mtDNA DAMPs) are then released into the
cytosol where they stimulate the recognition receptor (PRR) NLRP3 to activate caspase-1 which triggers
generation of proinflammatory cytokines. The mitochondrial base excision DNA repair (BER) pathway is
important to this process since increasing or decreasing BER capacity suppressed or accentuated,
respectively, mtDNA damage and ox-mDNA DAMP mobilization. BER also may be important in resolution of
the inflammatory response. Full recovery requires restoration of mitochondrial function, accomplished in part
by mitochondrial biogenesis. Mitochondrial DNA replication is a prerequisite for biogenesis, but replication
must not take place until the mutagenic base damage initiating inflammation is repaired. Thus, BER and
mtDNA replication must be faithfully coupled; if not, the resulting somatic mtDNA mutations would cripple
recovery, potentially leading to acute and post-acute complications. Despite these advances, events
underlying the transition between inflammation and its resolution are unclear. We now propose to test the
hypothesis that a signaling axis involving mtDNA repair and caspase-1 integrates processes essential
for initiation and resolution of NLRP3-dependent inflammation. Studies in cultured cells and intact
rodents will: (1) Determine how BER coordinates initiation and resolution of ox-mtDNA DAMP formation with
the intensity of inflammatory stress; and (2) Test the hypothesis that caspase-1 differentially regulates mtDNA
repair and replication to ensure that NLRP3-induced inflammation is appropriate for the severity of the
initiating stimulus while ensuring error-free, recovery-related mtDNA replication. This work is significant
because it will test a new hypothesis to explain how the inflammatory response initiated by NLRP3 is titrated
to the severity of the initiating stimulus and resolved without complications, including the potential introduction
of somatic variants into mitochondrial genome during resolution of inflammation. These studies are also
technically innovative; they will apply new mtDNA sequencing and isotopic labeling strategies to track the
formation and fate of proinflammatory ox-mtDNA as it relates to lung cell inflammation and resolution.

Public health relevance
PROJECT NARRATIVE The contribution of oxidative mitochondrial (mt) damage to lung injury, repair, and remodeling is undisputed, but mechanisms underlying associations between mtDNA damage and these pathophysiological events remain to be elucidated. Moreover, despite the severity and prevalence of these debilitating conditions, there are no specific biomarkers or therapies available to facilitate diagnosis and treatment. Thus, the goal of this proposal is to test the transformative hypothesis that a signaling axis involving mtDNA repair and caspase-1 integrates processes essential for initiation and resolution of NLRP3-dependent inflammation, and leverage these findings towards discovery of novel targets to treat acute lung injury.